PA1627: a new regulator of the Type III secretion system

Project Summary
New targets to combat Pseudomonas aeruginosa is paramount given the difficulty of treating
Pseudomonas infections and increasing drug resistance of this pathogen. A major goal has been
to target the type III secretion system that directly delivers toxins into host cells. However, this
has yet to result in a clinical therapeutic. We recently discovered an unannotated regulator,
PA1627, that controls expression of the type III secretion system. In this proposal, we will
determine the regulation of PA1627 and determine how PA1627 controls the type III secretion
system. Understanding this new level of control of the type III secretion can lead to new
possibilities for combatting P. aeruginosa.

Public health relevance
Project Narrative Pseudomonas aeruginosa can infect any tissue in the human body and is difficult to treat. This proposal will determine the regulation of a novel regulator of the type III secretion system. The results of this study will aid in developing improved therapeutic options for P. aeruginosa infections.